Regulation of Embryonic Stem Cell Self-Renewal

Project 1 will investigate the molecular basis of stem cell quiescence using the physiological phenomenon known as diapause as a model. We will also test whether similar molecular events occur in human pluripotent stem cells. Specific Aim 1 will use a diapause model to characterize stem cell quiescence in vivo, while Specific Aim 2 will characterize stem cell quiescence using novel in vitro models.

Public health relevance
We anticipate that the findings from these studies will shed light on how stem cells, including cancer stem cells, survive harsh environments.